Early Onset AD Consortium - the LEAD Study (LEADS)

Project Summary While the risk of Alzheimer’s disease (AD) increases with advancing age, approximately 5% of AD patients develop symptoms before age 65 (~280,000 Americans). The vast majority (90%-95%) of EOAD patients do not have a known mutation in APP or PSEN1/2, and only ~50% are APOE4 carriers. Unlike late-onset AD (LOAD), 30-64% of EOAD have non-amnestic presentations, leading to missed or delayed diagnosis. Despite being highly motivated and having few comorbidities, EOAD patients are commonly excluded from large scale observational biomarker studies (e.g. ADNI and DIAN) and therapeutic trials due to their young age, non- amnestic deficits, or absence of known pathogenic mutations. Furthermore, studies suggest high heritability in EOAD in the absence of known mutations or APOE4, signifying that this population may be enriched for novel genetic risk factors. Emerging biomarkers of amyloid and tau have not been systematically characterized in this population. Clinical and neuroimaging measures employed in LOAD may be insensitive to baseline deficits and disease progression in EOAD, which predominantly involve non-memory cognitive domains and posterior cortical neurodegeneration. To fill this gap in AD research, we plan to recruit and longitudinally follow 400 amyloid PET-positive EOAD subjects meeting NIA-AA criteria for MCI due to AD or probable AD dementia (including primary amnestic, dysexecutive, language and visuospatial presentations), 200 subjects meeting clinical criteria with negative amyloid PET (EOnonAD) and 100 age-matched controls. Participants in the Longitudinal Early-onset Alzheimer’s Disease Study (LEADS) will undergo clinical assessments, psychometric testing, MRI, amyloid ([18F]Florbetaben) and tau ([18F]AV1451) PET, CSF and blood draw for collection of DNA, RNA, plasma, serum and peripheral blood mononuclear cells (PBMC). EOnonAD participants and controls will also receive [18]FDG PET. All participants are followed annually (controls up to 24 months; impaired participants up to 48 months). Methods will be harmonized with ADNI and DIAN. We will comprehensively characterize cognitive, imaging and biofluid changes over time in EOAD and EOnonAD and compare to age-matched controls and sex and stage- matched LOAD participants identified in ADNI. We will employ machine learning algorithms to develop sensitive clinical and imaging measures of EOAD progression. Additionally, we will characterize demographic, clinical, neuroimaging, and fluid biomarker measures in EOnonAD cases to explore the possible etiologies of cognitive impairment. An exploratory aim will apply next generation sequencing to assess for novel genetic risk factors for disease. The study will also establish a network of EOAD research sites and set the stage for the launch of clinical trials in this population.

Public health relevance
Project Narrative Patients with early-onset Alzheimer’s disease (EOAD), occurring before age 65, are an understudied segment of the population of patients with AD, and many treatment studies exclude these younger individuals. In this project, we plan to recruit and follow 600 people with EOAD and related disorders in order to better understand changes in thinking abilities, changes in the brain, and changes in blood and spinal fluid, with the goal of using this information to design new treatment trials inclusive of this segment of the AD population.